Research Experience and Training Coordination Core

PROJECT SUMMARY (Research Experience and Training Coordination Core: Maier, Ramírez-
Andreotta, Ding)
The overarching goal of the University of Arizona Superfund Research Center (UA SRC) is to improve human
health impacted by mining activities. This requires understanding of how chronic exposure to dust generated
by metal-mining activities contributes to the development of nonmalignant lung disease combined with the
development of risk assessment tools to predict exposures and associated health outcomes and inform public
health prevention and interventions. Achieving this goal requires the development of transdisciplinary,
research-based, paradigm-shifting solutions to the multifactorial problems associated with the increased
demand for metals. The UA SRC Research Experience and Training Coordination Core (RETCC) supports
development of such solutions by preparing interdisciplinary graduates who are equipped to address and
mitigate complex 21st century hazardous waste challenges. The success of the UA SRC Trainee experience is
evidenced by the number of awards they receive and by their successful placement upon graduation into
sought after academic, regulatory, and industry positions. We will continue this success by investing in and
designing novel pedagogical experiences to ensure students are exposed to transdisciplinarity, collaboration,
knowledge integration, and stakeholder engagement. Our RETCC will surpass conventional approaches to
graduate student training by immediately immersing Trainees in community engagement (CE), research
translation (RT) and data management and analysis (DMA) activities, and emphasizing and developing a wide
variety of science communication skills. We will continue to build on the successful approach developed over
the past 34 years to guide our RETCC, which includes: (1) Career enhancement stipends, (2) Intensive and
extensive training opportunities in UA SRC projects and cores, (3) exposure to multiple scientific disciplines,
(4) A year-long course that combines monthly Colloquium with professional development, DMA, and science
communication activities and the requirement to perform a minimum of one RT or CE activity that supports the
Center, (5) Trainees who complete responsible conduct of research and human subjects training, and (6)
Providing multi-mentor apprenticeship opportunities. The RETCC will host up to ten Trainees per year to
participate in RETCC activities and in the Center’s overall research program, projects, and cores. RETCC
leadership and faculty mentors will leverage institution-wide and departmental support and efforts to recruit and
support our Trainees.

Public health relevance
PROJECT NARRATIVE (Research Experience and Training Coordination Core: Maier, Ramírez- Andreotta, Ding) Meeting future needs for metal mining will require close partnerships between academia and local communities, government, and industry that incorporate innovative, research-based solutions to the complex problems associated with the increasing demand for metals. The University of Arizona Superfund Research Center Research Experience and Training Coordination Core (RETCC) recognizes that such solutions will only be achieved by implementing integrated training programs that simultaneously address both the science and practical aspects of resource extraction, ultimately building new research capacity. Accordingly, the goal of the RETCC is to prepare scientists who are equipped to evaluate the technical challenges of metal mining, assess potential impacts on environmental and human health, and apply innovative strategies to manage and mitigate mining-related wastes.